Targeting the chromatin binding domains of BPTF for neuroblastoma epigenetic therapy

ABSTRACT
The goal of this proposal is to develop high-quality chemical probes to functionally annotate the epigenetic
effector “reader” domains within Bromodomain PHD Finger Transcription Factor (BPTF) in neuroblastoma (NB)
and to serve as new therapeutic leads. BPTF is an essential component of the nucleosome remodeling complex
NURF. Nucleosome remodeling complexes are emerging as important anticancer drug targets due to their role
in regulating chromatin accessibility and gene expression. We hypothesize that interfering with the chromatin
binding of BPTF will disrupt oncogenic regulatory networks present in cancer cells. Our preliminary data supports
a new tumorigenic role of BPTF in NB, an aggressive pediatric cancer which accounts for ~15% of cancer deaths
in children. Intriguingly, BPTF copy number gain is frequent in NB and high BPTF expression at initial diagnosis
is associated with increased risk of disease progression and recurrence. Reduction of BPTF protein levels using
genetic depletion resulted in robust loss of either MYC or MYCN and a concomitant loss of cell viability. Our
results are consistent with the reported role of BPTF in many adult cancers including melanoma, glioma, breast,
lung, and pancreatic cancer. However, high-quality chemical probes for BPTF are lacking, and the individual
roles of the BPTF chromatin binding domains for regulating these mechanisms in cancer have yet to be fully
elucidated. To address these shortcomings, we will develop chemical probes to assess the function of the BPTF
C-terminal plant homeodomain (PHD) and bromodomain (BRD) with respect to chromatin binding and
accessibility, transcriptional regulation of MYC and MYCN and their downstream targets, and anti-cancer activity.
In Aim 1, we will address liabilities of current BRD chemical probes and optimize ADME pharmacokinetic
properties; in Aim 2, we will develop PHD inhibitors using biochemical, structural, and biophysical assays; in Aim
3, we will establish an epigenetic mechanism linking BPTF, NURF, MYC, and MYCN in NB and evaluate the
roles of the individual BPTF chromatin binding domains. Optimized, drug-like BRD and PHD inhibitors will enable
in vivo evaluation of these compounds as therapeutic leads and offer starting points for PROTACs.
The innovation in our approach is the use of new structural biology methods based on room temperature
crystallography, protein NMR, and molecular dynamics for capturing dynamic protein states to facilitate structure-
based-design of selective inhibitors and virtual screening of over a billion small molecules. Our proposal benefits
from extensive preliminary data based on our second generation nanomolar-affinity BRD inhibitors BZ1 and BZ2,
the first room temperature crystal structures guiding our design, the first reported inhibitors developed from a
screen targeting the PHD finger, and BPTF domain-edited cancer cell lines. High-quality chemical tools emerging
from this project will enable the elucidation of the oncogenic roles of the BPTF chromatin binding domains in NB
and provide a potential therapeutic option for an aggressive cancer that lacks effective treatments. Furthermore,
our work will empower the research community to probe BPTF biology in other adult and pediatric cancers.

Public health relevance
NARRATIVE In this proposal, we will develop potent and selective chemical probes for both the bromodomain and plant homeodomain of BPTF, an epigenetic regulator that promotes cancer development and growth. We will evaluate the biological significance of inhibiting one or both BPTF chromatin binding domains in high-risk neuroblastoma, a deadly cancer that primarily affects children. Optimized, drug-like inhibitors will provide viable starting points for developing novel therapies treating neuroblastoma and other cancers.